Pediatric Oncology Research Training Program

PROJECT SUMMARY/ABSTRACT We are requesting continuation funds for a research training program in the Pediatric Oncology Program at the Fred Hutchinson Cancer Research Center and the Department of Pediatrics, University of Washington. The purpose of the proposed program is to train promising physicians to become independent investigative pediatric oncologists. In the first year of the program, which is funded by sources other than this grant, trainees receive intensive exposure to clinical care and clinical research. In their second and third years, the trainees commit themselves to a major research effort. Research projects in the areas of hematopoietic stem cell transplant research, leukemia/lymphoma immunology and immunotherapy, transplantation biology, normal and malignant hematopoiesis, human immunogenetics, neuro-oncology, cancer survivorship and molecular genetics, as well as other programs are available. The aim of the projects will be to contribute new and useful information relevant to pediatric oncology and to develop the research capabilities of the trainees to allow them to establish themselves as independent investigators. Physicians who have completed three years of training as residents in pediatrics will be eligible. Those most qualified and motivated to enter into investigative endeavors will be selected. In the past, many of the applicants have had previous laboratory experience. Of the thirty trainees supported by this NRSA who have completed their training during the past 15 years, 27 are in research positions: 21 in academic pediatric oncology, six in clinical trial development in industry. Three former trainees have clinical positions; one of whom has a pending academic appointment. We are requesting continued funding for two postdoctoral fellowships per year in a two-year program (a total of four positions). This program involves the laboratory and clinical research facilities of the Fred Hutchinson Cancer Research Center, Seattle Children's Research Institute, and the University of Washington. The clinical facilities of the Division of Pediatric Hematology-Oncology are located at Seattle Children's Hospital and the Seattle Cancer Care Alliance.

Public health relevance
PROJECT NARRATIVE This program will train physicians to meet the expected needs for physicians trained in laboratory and clinical research relevant for improving outcomes for children with cancer.